Is there a difference between transfusing old vs fresh blood in critical illness

First, canines with Staphylococcus aureus (S. aureus) pneumonia were randomized in a blinded fashion for exchange-transfusion with either 7- or 42-day-old canine commercially available universal donor blood. These experiments were designed to test the extremes of storage age and transfusion volume. Older blood transfusion increased mortality, the arterial-alveolar oxygen gradient and histological lung damage. Older blood resulted in increased in vivo hemolysis, releasing free iron (in the form of non-transferrin bound iron, NTBI) and cell free hemoglobin (CFH) and decreasing Haptoglobin (Hp) plasma levels. Consistent with the vasoconstrictive effect of CFH, older blood increased both systemic and pulmonary pressures. This was the first randomized blinded animal trial showing blood transfused at end of storage period can increase mortality during infection
Next, we investigated the effect of increasing bacterial doses and severity of infection on the risks associated with age of blood transfused. Without bacterial challenge, levels of CFH and NTBI were significantly higher with older versus fresher blood transfusion but there were no significant differences in measurable injury. With higher-dose bacterial challenge, the elevated NTBI levels declined more rapidly and to a greater extent after transfusion with older blood and was associated with significantly worse shock, lung injury, and mortality. These data suggest that transfused older RBCs increases the risks specifically from infection in septic subjects and define an infection dose-response
To determine whether transfusion of older RBCs would cause similar adverse effects during shock and inflammatory injury without infection, animals were transfused similar quantities of either older or fresher stored universal donor canine RBCs 2.5 hours after undergoing controlled hemorrhage producing shock. With older transfused RBCs, CFH and NTBI levels increased, but lung injury declined and there was a trend toward lower mortality (18% vs. 50%). Interestingly, the increased levels of CFH with older blood transfusion were associated with an improved hemodynamic response to hemorrhage-reperfusion, with lowered exogenous norepinephrine requirements and cardiac outputs. This hemodynamic effect is consistent with the ability of CFH to scavenge NO causing vasoconstriction. These preclinical data suggest that, whereas iron derived from older RBCs promotes bacterial growth worsening septic shock mortality during infection, release of CFH and NTBI during hemorrhagic shock is not necessarily harmful
A blinded randomized controlled study of RBC washing was performed in this canine model. Washing older units of blood improved survival rates, shock score, lung injury, cardiac performance and liver function, and reduced levels of NTBI, possibly by lysing and washing away older cells and supernatant. In contrast, washing fresh blood worsened all these same clinical parameters and increased CFH levels. Our data suggest that fresh blood should not be washed routinely because washing induces sub-lethal membrane damage to the RBC and, in a setting of established infection, washed RBCs are prone to lyse, release CFH, and result in worsened clinical outcomes. However, if older blood must be used during established infection, washing prevents elevations in plasma circulating iron and improves survival and lessens multiple organ injury. Washing blood stored for intermediate ages does not alter risks of transfusion or NTBI and CFH clearance
When transfused with increasing volumes of old or fresh blood either unwashed or washed RBCs with increasing storage age. Our preclinical data suggest that any volume of older blood potentially increases risks during established infection. In contrast, even massive volumes of fresh blood resulted in minimal CFH and NTBI levels and risks.
During canine experimental bacterial pneumonia, treatment of mild anemia with IV iron significantly increased free iron levels, shock, lung injury, and mortality compared to transfusion of fresh RBCs. This was true for iron preparations that do or do not blunt circulating free iron level elevations. These findings suggest that treatment of anemia with IV iron during infection should be undertaken with caution
Storage temperature is a critical factor for maintaining RBC viability, especially during prolonged cold storage. The target range of 1-6C was established decades ago and may no longer be optimal for current blood-banking practices. We completed a study investigating the role of storage temperature and showed the lower bounds of the regulated storage temperature range resulted in greater recovery of transfused RBCs and less hemolysis with release of potentially harmful byproducts such as CFH and iron. Storage at refrigeration temperatures closer to 2C may result in a better product for transfusion and more accurate for chromium RBC viability testing. This study shows that current blood storage practice standards may not adequately account for an important interaction between storage time and temperatures that may confound chromium RBC viability testing and prove clinically relevant
In both human septic shock and our canine pneumonia model CFH levels are elevated. Presumably, virulent bacteria produce factors which lyse RBCs, liberating CFH. Elevated CFH could scavenge nitric oxide (NO) resulting in endothelial damage and vasoconstriction. The iron in CFH possibly serves as an essential nutrient promoting bacterial growth or contribute to oxidative tissue injury or augments inflammation. Indirect evidence suggests both CFH-NO scavenging and Iron- related mechanisms could cause injury during infection. In our canine pneumonia model, transfusion of RBCs results in elevated CFH and iron levels and increased lethality of S. aureus. We determined an elevated plasma CFH, is not only a marker of risks of death but also a toxic substance, directly involved in the pathogenesis of bacterial pneumonia and death. Administration of intravenous CFH worsened lung parenchymal injury as measured by the arterial alveolar gradient only in the presence of bacterial infection. Thus CFH is not a direct toxin to the lung parenchymal, but rather interacts with the infection to cause damage. This contrasts with the direct effects of CFH on the pulmonary vasculature increasing pressures both in the presence and absence of infection. These two different mechanism of lung injury impacted survival. This is clinically important since elevated CFH levels in human septic shock are associated with a worse outcome and RBC transfusion is common in patients with sepsis. Human Hp concentrate (Hp) infusion in our canine pneumonia model resulted in the clearance of both iron and CFH, as Hp complexes with CFH to produce a large molecule which remains intravascular until it is cleared by the liver. Independent of receiving RBC transfusion, Hp infusion in septic animals resulted in improved shock, lesser lung injury, and lower mortality. This study is intended to identify the specific mechanism(s) by which hemolysis increases injury in septic shock and how Hp is beneficial.
CFH released into the plasma due to hemolysis is mostly found in the oxidative form, oxyhemoglobin (OxyHb). In an antibiotic treated model of sepsis, giving an infusion of >99% pure OxyHb alone without any cellular products released from disrupted RBCs resulted in a significant increase in shock, lung injury and mortality. Thus, we found that CFH alone can increase injury during sepsis and further there are two separate mechanisms by which CFH can worsen outcomes. The first is dependent on the presence of infection where the availability of iron worsens the infection. The second is independent of infection and related to an intrinsic NO scavenging property causing vasoconstriction. Unexpectedly, we found without antibi